A Biobehavioral Intervention to Reduce Adverse Outcomes in Young Adult Testicular Cancer Survivors

Project Abstract
This application is responsive to the call for “Administrative Supplements on Long-term Cancer
Survivorship" and focuses on long-term young adult survivors of testicular cancer. Testicular cancer is the
most common malignancy among young adult males. While survival rates exceed 95%, long-term survivors
are at risk for persistent psychological distress, occupational disruption, cognitive concerns, and diminished
quality of life. These late effects are especially concerning among those diagnosed in young adulthood—a
developmental period marked by goal pursuits, identity formation, and career establishment. However, few
studies have examined the self-regulatory mechanisms that may sustain resilience or contribute to risk across
long-term survivorship.
Our team is currently testing Goal-focused Emotion-Regulation Therapy (GET) in recently treated young
adult testicular cancer survivors (parent award: R01CA276143). GET targets goal navigation and emotion
regulation—two transdiagnostic skills central to adaptation. Preliminary data suggest GET improves
psychological outcomes and stress biology in early survivorship. Yet, it remains unknown whether these core
mechanisms remain relevant years after diagnosis. The objective of this cross-sectional supplemental study is
to evaluate the biopsychosocial and occupational correlates of self-regulation in 100 long-term young adult
testicular cancer survivors (≥5 years post-diagnosis, diagnosed at ages 18–39). We will 1) Characterize
biopsychosocial and occupational burden (e.g., mood symptoms, cognitive concerns, fatigue, financial toxicity),
alongside GET-targeted mechanisms (goal navigation, emotion regulation, personal agency); 2) Test
associations between goal navigation and psychosocial, occupational, and biological outcomes. We
hypothesize that stronger goal navigation relates to lower distress, better quality of life, and higher agency.;
and 3) Examine emotion regulation in relation to these same outcomes. We anticipate that adaptive emotion
regulation will be associated with more favorable functioning across all domains.
Findings will clarify whether self-regulatory capacities remain operative in long-term survivorship, informing
intervention adaptation, survivorship guidelines, and future longitudinal models of resilience in AYA cancer
survivors.

Public health relevance
Project Narrative This study will examine how self-regulatory processes—specifically goal navigation and emotion regulation— relate to psychological and occupational outcomes in long-term young adult testicular cancer survivors. Findings will clarify whether the skills targeted by a novel intervention (Goal-focused Emotion-Regulation Therapy) remain relevant years after diagnosis. Results will inform survivorship care strategies aimed at sustaining long-term well-being and functional recovery in young adult testicular cancer survivors.